Combined single-molecule fluorescence confocal and dual-trap optical tweezers

Cover Page: Descriptive Title: Combined single-molecule fluorescence confocal and dual-trap optical tweezer Proposed Project: 02/01/2021 and end date of 01/31/2022 Estimated Project Funding: Total Federal Funds Requested: $ 600,000 Total Non-Federal Funds: $ 0 Total Federal & Non-Federal Funds: $ 600,000 Program Income: $ 0 Major Users: Dr. Baron Chanda Dr. Eric Galburt Dr. Roberto Galletto Dr. Michael Greenberg Dr. Timothy Lohman Dr. Janice Robertson Dr. Andrea Soranno Dr. Meredith Jackrel Minor User Dr. Alex Holehouse Dr. Michael Vahey

Public health relevance
PROJECT NARRATIVE The combination of single-molecule force and fluorescence spectroscopy provides an innovative tool for interrogating protein-protein, protein-nucleic acids, and protein-lipid interactions. This novel approach will provide essential new information on: i) the role of DNA helicases in maintaining genome stability, with potential implications on the development of new antibiotics and cancer prevention; ii) the molecular determinants that make apolipoprotein E the major genetic risk factor for Alzheimer’s disease, iii) the folding of membrane proteins; iv) the material properties of biomolecular condensates.